INTRINSIC NEUROMODULATION OF A SMALL NEURONAL NETWORK

DESCRIPTION (Adapted from applicant's abstract): The cellular mechanisms of neuromodulation has been well studied, yet surprisingly little is known about how neuromodulatory actions are dynamically processed and controlled by neuronal circuits. This study will use the well-characterized central pattern generator circuits underlying the rhythmic escape swim of the nudibranch mollusc, Tritonia diomedea, to examine how the neuromodulatory actions of identified serotonergic neurons intrinsic to the circuit are integrated in the basic operation and plasticity of that circuit. Four aspects of the dynamic control of and response to serotonin (5-HT) signaling will be addressed. 1) The effect of neurotransmitter content. The serotonin precursor, 5-hydroxytryptophan (5-HTP), increasingly is being used as a nutritional supplement by the lay public for self-treatment of mental illnesses, yet very little is known about how altering the 5-HT content of neurons affects their function. This study will examine how the actions of identified serotonergic neurons in a well-defined network are affected when their 5-HT content is pharmacologically manipulated using treatments such as exposure to 5-HTP or 5-HT depletors. 2) The spatiotemporal nature of 5-HT signaling. To better understand the spatial organization of intrinsic neuromodulation, the projection patterns of identified serotonergic neurons will be mapped using confocal laser scanning microscopy of 5-HT immunoreactivity and dye fills. This will be correlated with microvoltammetric recordings to locate probable 5-HT release sites. The sensitivity to 5HT will then be mapped using photolysis of caged 5-HT to trigger local increases in 5-HT concentration. The temporal information content in the 5HT signal will be examined using rapid uncaging of 5HT to alter the ongoing motor pattern. 3) Feedback control over 5HT release. Electrophysiological techniques will be used to test the hypothesis that the activity of the serotonergic neurons is regulated by synaptic feedback that controls the total amount of 5HT released during the behavior. 4) Biochemical integration of modulatory signals. The integration of biochemical changes generated by temporally varying serotonergic signals will be explored through manipulation of second messengers in this system. Altogether, these experiments, performed on a well-characterized simple system, will provide a basis for understanding how more complex systems integrate and control neuromodulatory information and thus provide insight into many forms of behavioral plasticity.